Mechanisms of nuclear egress in herpesviruses

PROJECT SUMMARY/ABSTRACT
Herpesviruses use an unusual pathway to export their capsids from the nucleus where they are formed into the
cytoplasm where they mature into infectious virions. Instead of using the canonical route through the nuclear
pore, capsids undergo budding at the inner nuclear membrane to form perinuclear enveloped virions that
subsequently fuse with the outer nuclear membrane, releasing the capsids into the cytoplasm. The nuclear
egress complex (NEC), composed of two virally encoded proteins, is the key player in the membrane budding
stage of this process. Previously, we discovered that the NEC from the prototypical a-herpesvirus, herpes
simplex virus 1, is a complete virally encoded membrane-budding machine, the only one currently known to
mediate budding of the nuclear, as opposed to cytoplasmic, membranes. We also showed that the NEC deforms
and buds membranes by using a dual mechanism, in which membrane curvature is generated both locally (by
peripheral membrane insertion) and globally (by the formation of a curved oligomeric scaffold). In addition, we
have determined the high-resolution structures of several NEC homologs that are now used to guide functional
studies. These results have transformed our understanding of how herpesviruses manipulate host membranes.
The current application builds logically on these and other recent achievements and will leverage the combined
power of structural and functional approaches to fill in the critical gaps in our understanding of both budding and
fusion stages of nuclear egress. Aim 1 will expand the mechanistic and structural studies of the NEC to homologs
from the distantly related g-herpesviruses. Aim 2 will visualize the nuclear egress process in infected cells in situ
at a high resolution using cryoelectron tomography. Aim 3 will characterize a new host factor promoting fusion during
nuclear egress. Our prior studies made important contributions to the current knowledge of how herpesvirus
capsids bud at the nuclear envelope. We anticipate that upon successful completion, the proposed work will
uncover new mechanisms and generate new models, thereby transforming our understanding of nuclear egress.

Public health relevance
PROJECT NARRATIVE Herpesviruses infect most of the world’s population for life, typically alternating between a dormant state and reactivation that causes several ailments ranging from cold sores and genital herpes to blindness, encephalitis, cancers, and life-threatening conditions in immunocompromised individuals and newborns. Nuclear egress – the process by which viral capsids are exported from the nucleus into the cytoplasm – is essential for production of new viral particles and conserved across all herpesviruses. Here, we propose to characterize its molecular mechanism, which may open new opportunities for pan-herpesviral therapeutic strategies based on blocking the release of new viral particles.